HSR&D Research Career Scientist Award

My research focuses on understanding and improving chronic pain management for Veterans by leveraging
my expertise in health communication, patient engagement, and relationship-centered care. Over the past 14
years, my work has developed from observational to interventional, steadily increasing the impact of my
scholarship on Veterans’ care. My research has helped to advance our understanding of how communication
shapes healthcare experiences and Veterans’ pain management. Early observational work led to insights into
the role of the patient-provider relationship and social support in pain self-management, treatment decision-
making, and opioid management, including opioid tapering. I have successfully built upon these findings with
each new project, which has led to the design and testing of interventions to improve pain management for
Veterans. These interventions have included developing and testing a peer-supported pain self-management
program, a coaching program designed to increase patient activation for Black Veterans with chronic pain to
help address racialized disparities in pain management, and a shared decision-making intervention to
overcome patient-level barriers to use of and adherence to evidence-based nonpharmacologic pain
treatments. Beyond developing and testing interventions, I am also moving toward implementation in an effort
to broaden my impact and improve care for Veterans. My health equity study, COOPERATE, significantly
increased patient activation and communication self-efficacy, while producing other positive outcomes for
Black Veterans. In light of these positive results I will be exploring avenues for implementation through our
operational partners as well as likely submitting a proposal for a Hybrid Type 2 multi-site
effectiveness/implementation study, to further test COOPERATE and prepare for system-wide implementation.
COOPERATE represents an important path to achieving health equity for Black Veterans with chronic pain and
as such, also represents the increasing impact of my research. My newly-funded study, OPTIONS, also has
direct relevance for Veteran care and impact. OPTIONS reflects VA’s priorities of reducing reliance on opioids
and increasing use of multimodal care, including evidence-based complementary and integrative therapies and
other nonpharmacologic approaches to chronic pain. As such, I have partnered with the VA National Pain
Management, Opioid Safety, and Prescription Drug Monitoring Program Office and the Office of Patient-
Centered Care and Cultural Transformation, and, assuming positive results, these partnerships will help
increase the project’s impact by facilitating VA-wide dissemination and, ultimately, implementation. These
examples reflect the evolution of my work from early observational studies to intervention studies, which will
ultimately lead to system-wide implementation and greater impact on Veterans’ pain care. The other study I am
currently leading as co-PI, CIPHER, is focused on understanding effects of COVID-19-related disruptions in
pain care on Veterans with chronic low-back pain, with particular emphasis on disruptions to nonpharmacologic
care, which can be more difficult to deliver via telehealth. Using a mixed-methods design with VA
administrative data and qualitative interviews with clinicians and Veterans purposefully sampled from the
administrative data, we are partnering with the VA National Pain Management Office to understand changes in
care and, ultimately, apply these lessons to improving pain care for Veterans.

Public health relevance
Chronic pain affects two-thirds of Veterans and is associated with depression, anxiety, and reduced quality of life. My research career has been devoted to understanding and improving pain management for Veterans. I began this work by conducting observational research to understand how pain is discussed in clinic visits, how patients and doctors make decisions about pain treatment (including opioids), and how social support facilitates pain self-management. Building on these findings, I have advanced my work to design and test interventions to improve pain management, including interventions to support patients’ efforts at pain self- management and to help patients become more engaged, active participants in their chronic pain care. As my interventional work progresses, it will also include plans to implement effective interventions system-wide in the VA, thereby maximizing the impact of my research and improving Veterans’ pain management.